Progress in Vaccine Development for Infectious Diseases

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Progress in Vaccine Development for
Infectious Diseases, organized by Drs. Katalin Kariko, Karin Loré and Norbert Pardi. The conference will be
held in Breckenridge, Colorado from June 1-4, 2022.
Vaccines are the cornerstones of modern medicine, saving millions of lives every year. Due to the fast
progress in better understanding the biology of certain pathogens coupled with recent technological advances
in the fields of immunology, structural biology and nanomaterial development, science has entered a new
golden age of vaccinology. This conference will focus on presenting state-of-the-art vaccine technologies
(mRNA, viral vectors, protein nanoparticles, adjuvants), recent advancements in understanding (and potentially
manipulating) vaccine-induced immune responses and key aspects of structure-based antigen design that
allows us to develop better vaccine immunogens. Combining these overlapping and strongly synergistic
aspects of vaccine development will foster collaborations between conference participants that may result in
novel, very effective vaccines in the future. Moreover, most of the currently used vaccines have been
developed by empirical research without the involvement of immunologists, structural biologists or biomedical
engineers. However, it has become evident in recent years that the empirical approach is not sufficient for
successful vaccine development against hard-to-target pathogens. To successfully combat these pathogens,
the community needs to better understand how to induce protective immune responses against them and need
to develop better adjuvants, vaccine platforms or immunization schemes. This "combined" approach requires a
tight cooperation between interdisciplinary groups of scientists who will all be in attendance at this Keystone
Symposia conference. Finally, the program includes a session focused on vaccine diplomacy, to address key
challenges regarding vaccine production and distribution and advocate for a more equitable system for
worldwide vaccine distribution.

Public health relevance
PROJECT NARRATIVE This conference will present an opportunity for scientists from varying backgrounds to join forces and forge the development of new and more efficacious vaccines, leveraging many recent technological advances in this critical area of pandemic preparedness. To date, modern medicine has only been able to develop highly effective vaccines against a subset of human pathogens; vaccines are still needed for many critical hard-to- target pathogens. By combining the knowledge and scientific expertise of the researchers at this conference, it will accelerate the development of safe and effective novel and life-saving vaccines.